Impact of El Nino on Environmental Mercury and Human Exposure

? DESCRIPTION (provided by applicant): Beginning in November 2015, Peru will experience one of the largest El Niño climate events on record. Scientists have historically focused on studying impacts from El Niño in coastal areas due to relatively dry regions experiencing large-scale flooding. Research has largely overlooked the effects of El Niño in the Amazon and its consequences for human health beyond vector-borne disease risk. The Madre de Dios (MDD) region of the Peruvian Amazon is expected to face a challenging El Niño season with over 90% of the population experiencing both excessive drought and flooding. These environmental changes are coupled with an ongoing social challenge: artisanal small-scale gold mining (ASGM) that has rapidly expanded due to construction of the Interoceanic Highway. ASGM releases inorganic mercury (Hg) directly into proximate soil and river sediment, where anaerobic bacteria bio-methylate Hg to form the potent neurotoxicant methylmercury (MeHg) that biomagnifies in the aquatic food web. Communities near and far downstream from ASGM are exposed to high levels of MeHg via consumption of contaminated fish. Our primary hypothesis is that El Niño is associated with increased human MeHg exposure due to elevated rates of Hg bio-methylation in aquatic ecosystems and increased fish consumption. We hypothesize that: (1) El Niño will disrupt agricultural production, leading to increased reliance on fish protein; () Hg released into the environment by ASGM will undergo more rapid bio-methylation due to higher bacterial activity in sediment caused by El Niño- related flooding; (3) fish in flooded rivrs downstream from ASGM and sold in markets will contain higher levels of MeHg; and (4) environmental Hg exposures in adults, children, and developing fetuses will increase with higher dietary exposure and nutritional vulnerability. We will develop a predictive model for human internal MeHg dose that accounts for El Niño-related environmental changes. Our team is uniquely positioned to evaluate the impact of El Niño in the Amazon by leveraging ongoing research in MDD with prior data collected on Hg levels in environmental and human biological samples. In addition, we leverage our long-term collaborative partnerships with community leaders and the Ministry of Health to assist in implementation of our aims. To test our hypotheses, we will collect additional primary data by testing fish, sediment and human biological samples for Hg and other metals in areas and people previously sampled by our team during and following El Niño, conduct monthly food frequency surveys in sentinel households (previously sampled), and initiate a birth cohort (enrolling 10 children per month). Results from this proposed study will help establish whether El Niño flooding is associated with increased MeHg exposure, identify sources of exposures, and determine exposure thresholds associated with observable health effects among persons living in the Amazon. As El Niño events occur regularly and are projected to intensify in the future, this project has significant potential to inform future disaster preparedness and to protect the wellbeing of vulnerable regional populations.

Public health relevance
PUBLIC HEALTH RELEVANCE: Artisanal small-scale gold mining (ASGM) is the leading cause of mercury pollution worldwide. ASGM releases inorganic mercury that is bio-methylated by sediment bacteria into methylmercury (meHg), which is a potent neurotoxin that biomagnifies in the aquatic food web and, importantly, in fish populations harvested for human consumption. Bio-methylation occurs more rapidly during flood events, such as what is predicted to occur during the impending El Niño. This study will help determine the extent of increased bio-magnification of meHg in fish populations due to El Niño-related flooding and the resulting increase in meHg detected in biological samples from vulnerable populations of the Peruvian Amazon, in particular, pregnant women and children.